Microelectrodes for Co-Localized Tunable Drug Delivery and Neural Recording

Each year, thousands of Veterans experience neurologic injury or disease resulting in severe motor
dysfunction, with devastating consequences for the affected individual and their loved ones. Intracortical
brain-machine interfaces (iBMIs) offer a compelling solution for restoring volitional control of computer
cursors, robotic arms, and functional electrical stimulation-controlled limbs. However, iBMI functionality is
reliant upon our ability to detect neuronal signals at indwelling microelectrodes for a period of years to
decades. This requirement is challenged by the biological response to the implant, which impedes
communication between healthy neurons and the implanted microelectrodes. Successful iBMI clinical
translation, and the resulting gains in functional independence for users, hinges upon improving the quality
and stability of the biotic-abiotic interface.
The standard materials used for intracortical microelectrode devices are rigid materials, such as silicon,
which can cause chronic tissue damage that exacerbates the biological response. Some groups have developed
flexible polymer-based devices, though these usually require reinforcement to prevent buckling during
insertion. Local pharmacologic delivery can also be used to control the tissue response, though is typically
either short-lived as drug-loaded coatings are depleted, or requires complex and invasive fluidic systems.
Our approach combines advanced structural and microelectrode materials to provide a two-pronged
approach to attenuating the inflammatory tissue response without requiring complex fluidic delivery systems.
A mechanically-adaptive polymer nanocomposite (NC) provides a structural material that is sufficiently stiff
insert into the cortex, yet dramatically softens within minutes of insertion to minimize chronic differential
tissue strain. Highly-ordered, vertically-oriented titania nanotube arrays (TNAs) will perform both drug-
releasing intracortical microelectrode recording sites. TNAs are highly tunable materials that can efficiently
store pharmacologic agents that slowly diffuse into tissue over weeks to months with a release profile governed
by the nanotube geometries. Chemical doping processes enhance TNA conductivity to facilitate sensing
neuronal activity. We hypothesize that combining soft structural materials with sustained anti-inflammatory
drug delivery will lead to synergistic improvements in tissue response and long-term neural recording quality.
We will first investigate the relationship between anti-inflammatory release kinetics and the inflammatory
response. Devices comprise TNA microsegments integrated into the NC. Dexamethasone, a representative anti-
inflammatory corticosteroid, will be loaded into either the NC or into the TNAs to provide rapid and sustained
(>8 weeks) release profiles, respectively. Devices will be implanted into wild-type mice for up to 1, 2, 4 or 8
weeks. At each timepoint, local inflammatory markers in tissue will be evaluated for the two experimental
groups and for non-releasing and sucrose-releasing controls. This study will be used to evaluate the time course
of the inflammatory response to two different release profiles and assess in vivo DEX release from TNAs.
In the second study, we will take advantage of both the drug delivery and electrical properties of the TNAs.
We will fabricate NC-based neural probes with recording functionality using the TNAs as the recording sites at
which neural activity is detected. Probes will be implanted into the primary motor cortex of wild-type mice for
16 weeks. Throughout the implant period, neural activity, electrochemical impedance, and fine motor behavior
will be assessed, which will be followed by post-mortem quantification of cell types. We will evaluate the
contributions of soft materials, local pharmacologic intervention, and microelectrode recording site material.
We expect that sustained (>8 weeks) pharmacologic release directly from the recording sites will result in
substantial improvements in neural recording stability that will help to advance iBMI technology toward safe
clinical use with long-term reliability.

Public health relevance
The Department of Veterans Affairs provides care for more than 27,000 Veterans with spinal cord injury, which is just one of many conditions that can severely affect the ability to interact with the environment under one’s own volition due to severe motor disability. All aspects of daily life are affected, ranging from basic personal care to social interactions to transportation and occupations. Intracortical brain-machine interfaces by-pass the injured or diseased portion of the nervous system to restore volitional control of machines or peripheral muscles. Our objective is to advance this technology to a state in which it can safely and reliably be used in clinical applications to restore functional independence to those affected by severe motor disability. Toward this end, we are integrating innovative materials that provide a multi-pronged approach to lessening the response launched by the body to isolate the implant from brain tissue. We expect that our materials- focused technology will dramatically improve the long-term stability of intracortical brain-machine interfaces.